Rapid ID and AST Directly from Whole Blood Using Single Molecule Detection

Project Summary
Standard identification (ID) and antimicrobial susceptibility testing (AST) of bloodstream pathogens are
conducted using slow methods that require blood culture. Diagnostic results are available three or more days
after the diagnostic process is started. The lack of rapid diagnostic results forces physicians to treat patients with
broad-spectrum antibiotics which are not effective against a growing number of resistant organisms and can
induce the development of more antimicrobial resistance. Here, we propose the development of a rapid
diagnostic platform that, if successful, will enable effective and targeted therapy of bloodstream infection patients
within hours.
The new platform will directly analyze whole blood samples using a simple and robust single molecule detection
approach called Single MOlecule Tethering or SMOLT. The platform will be rapid (ID in one hour and AST in 4-
6 hours), easy-to-use, and cost-effective. Our preliminary results show that a SMOLT multiplex assay can detect
bacteria in blood with limits of detection (LOD) between 1-10 CFU/mL with a turn-around-time of about an hour.
The same technique can be used for AST. Preliminary results show that a brief incubation with an antibiotic
follow by SMOLT detection can be used to determine if a strain is susceptible, intermediate or resistance in high
agreement with the category assigned be a standard reference method. In aim 1, we propose the development
of a SMOLT multiplex ID assay capable of detecting and identifying the rRNA of six highly relevant pathogens
directly in whole blood. The goal of aim 2 is to develop a SMOLT phenotypic AST assay for combinations of the
six ID species and 14 relevant drugs. Our third aim is to develop a prototype instrument for the SMOLT ID and
AST assays that is easy-to-use with minimum hands-on-time. The last aim is to evaluate the ID and AST assays
using blood samples seeded with a combination of fresh and stock clinical isolates as well as type strains.

Public health relevance
Project Narrative We propose the development of a novel sample-to-answer ID/AST test for rapid identification and phenotypic antimicrobial susceptibility testing of bacteria directly on whole blood for the diagnosis of patients suspected of bloodstream infections.